Postdoctoral Research Associate Training Program (PRAT)

The NIGMS Postdoctoral Research Associate Training (PRAT) Program's overarching goal is to provide high quality postdoctoral research training in the basic biomedical sciences, in NIH intramural research laboratories, to a group of postdoctoral fellows to prepare them for leadership positions in biomedical careers. The research projects focus on NIGMS mission-related areas of basic biomedical science. These include biological chemistry, biophysics, bioinformatics, cellular and molecular biology, developmental biology, genetics, immunology, neuroscience, pharmacology, physiology, and technology development. Studies employing a variety of research organisms are encouraged.

Publications are included as part of the IR research mentor's reports.

All PRAT Fellows are IRTAs.

PRAT Fellows and Preceptors, Class of 2022, effective September 1, 2022:

Jonathan Chow, PhD
Yavin Shaham, PhD (NIDA)

Amber Lockridge, PhD
John Hanover, PhD (NIDDK)

Theodore Busby, PhD
Thomas Misteli, PhD (NCI)

Ian Lewis Morgan, PhD
Keir Neuman, PhD (NHLBI)

Rilee Zeinert, PhD
Gisela Storz, PhD (NICHD)

Sierra Marker, PhD
Martin Schnermann, PhD (NCI)

John Joseph O'Malley, PhD
Mario Penzo, PhD (NIMH)

Stephanie Lena Sarbanes, PhD
Antonia Roll-Mecak, PhD (NINDS)

PRAT Fellows and Preceptors, Class of 2023, effective September 1, 2023:

Jong Park, PhD
Brant Weinstein, PhD (NICHD)

Ashira Lubkin, PhD
Michail Lionakis, PhD (NIAID)

Adriana Alexander, PhD
Humphrey Yao, PhD (NIEHS)

Julian Rey, PhD
Peter Basser, PhD (NICHD)

Melesse Nune, PhD
Susan Buchanan, PhD (NIDDK)

Stefan Katharios-Lanwermeyer, PhD
Anupama Khare, PhD (NCI)

Elisha Segrist, PhD
Yasmine Belkaid, PhD (NIAID)

Ryan Cupo, PhD
Richard Youle, PhD (NINDS)

PRAT Fellows and Preceptors, Class of 2024, effective September 1, 2024:

Dennis Zhu, PhD
Gisela Storz, PhD (NICHD)

Joseph Cleary, PhD
Antonina Roll-Mecak, PhD (NINDS)

Claire Gao, PhD
Michael Krashes, PhD (NIDDK)

David L. Haggerty, PhD
David Lovinger, PhD (NIAAA)

Ryan Marquardt, PhD
Francesco DeMayo, PhD (NIEHS)

Leslie Ronish, PhD
Lauren Porter, PhD (NLM)

Ryan E. Tyler, PhD
Lorenzo Leggio, MD, PhD (NIDA)

David Castellano, PhD
Carlos Tristan, PhD (NCATS)